Investigating the synaptic trafficking of endogenous AMPARs

Project Summary
Changes to synaptic architecture underlie the cellular basis for learning and memory and
impaired synaptic function and plasticity are observed in numerous brain diseases and
disorders including epilepsy, autism, and schizophrenia. The synthesis and precise delivery of
AMPA-type glutamate receptors (AMPARs) to the postsynaptic membrane is a critical
mechanism for proper basal synaptic function and plasticity. How new receptors are delivered to
specific synapses and how receptor trafficking is influenced by neural activity remain important
questions. A major limitation for addressing these questions is the current reliance on non-
physiological, overexpressed receptors to study neuronal synaptic protein trafficking pathways.
To overcome this hurdle, I have developed and validated a new toolkit that allows me to label
endogenous AMPARs and control their trafficking. I propose to leverage these new tools to
investigate where, when, and how new AMPARs are delivered to specific synapses under basal
conditions and following diverse forms of synaptic plasticity.

Public health relevance
The synthesis, delivery, and precise localization of AMPA-type glutamate receptors (AMPARs) within the postsynaptic membrane is essential for basal synaptic function and plasticity. In order to determine how new receptors are delivered to specific synaptic connections at the appropriate time and abundance in large and geometrically complex cells like neurons, we present the use of a novel tool for visualizing and inducibly manipulating endogenous AMPAR synaptic trafficking.